Inhibiting CD4+ Th2 development and function by CFTR activity

PROJECT SUMMARY
Allergic disease is a chronic inflammatory state where CD4+ T cells manifest a biased T helper 2 (Th2) cell
differentiation and effector phenotype. The polarization and ultimate effector function requires timed and
transient intracellular signaling regulated by positive and negative hemostatic factors. One such negative factor
we recently identified is the cystic fibrosis transmembrane conductance regulator (CFTR) protein. Both asthma
and allergic bronchopulmonary aspergillosis (ABPA) are more common in patients with cystic fibrosis (CF, the
disease due to mutations in CFTR) and represent an exuberant CD4+ Th2 cell inflammatory response,
suggesting that CD4+ Th2 cells may be important in CF airway disease. We have studied the adaptive
inflammatory response to Alternaria alternata, a ubiquitous fungal aeroallergen that is associated with severe
asthma in Cftr-/- mice and found that compared to Cftr+/+ mice, Cftr-/- mice produce higher levels of the Th2
cytokines, IL-5 and IL-13. Moreover, Cftr-/- CD4+ T cells have increased in vitro Th2 polarization and cytokine
production compared to Cftr+/+ CD4+ T cells, suggesting that the absence of functional CFTR produces an
exaggerated Th2 response. Furthermore, we have found that the master regulator of Th2 cell differentiation
and function, GATA3, binds to the murine Cftr promoter following CD4+ T cell activation. Based upon these
preliminary results we hypothesize that CFTR functions to inhibit CD4+ T cell Th2 polarization and cytokine
production, and that CFTR expression is driven by GATA3 transcriptional activity. In Specific Aim 1 we will
determine the role of CFTR in negatively regulating CD4+ Th2 polarization and effector function. We will define
whether CFTR signaling is sufficient to inhibit Th2 polarization using CFTR overexpression in murine naïve
CD4+ T cells and whether endogenous CFTR expression inhibits Th2 cytokine production in Th2 polarized
murine CD4+ T cells. Specific Aim 2 will determine the importance on GATA3 binding on CFTR expression. We
will delineate whether GATA3 overexpression or transcriptional repression is sufficient or necessary for CFTR
expression, respectively. In Specific Aim 3 we will determine if CFTR modulation using recently FDA approved
small molecules capable of correcting or potentiating mutant and wild-type CFTR, 1) decreases Th2
polarization and/or effector function in healthy or CF human CD4+ T cells, 2) reduces Alternaria alternata
induced adaptive inflammation in a murine model expressing CFTR modulator-sensitive human CFTR, and 3)
decreases type 2 inflammatory biomarkers (IgE and eosinophils) in individuals with CF post-CFTR modulator
therapy compared to pre-CFTR modulator levels. Together these studies hold promise of elucidating the
importance of CFTR in CD4+ T cell biology and may represent a novel therapeutic approach to Th2 mediated
allergic disease. Importantly, this award will provide training in immunology from world-renowned
immunologists and cellular biologists to further my long-term goal of becoming an independent physician
scientist with expertise in pulmonary manifestations of CD4+ T cell mediated allergic disease.

Public health relevance
PROJECT NARRATIVE CD4+ T cells from Cftr deficient mice have recently been shown to have increased CD4+ Th2 cytokine production, and our preliminary studies suggest CFTR may function as a GATA3 responsive negative regulator of CD4+ Th2 polarization and effector function. In this proposal, we will use CD4+ T cells from mice and humans, a murine in vivo allergen model of Th2 inflammation, and electronic health record data to investigate the mechanisms of CFTR in Th2 inflammation and test whether CFTR modulation can reduce allergic inflammation.